Skeletal Myopathy in Systemic Sclerosis: Devising a Classification Schema Predictive of Outcomes

PROJECT SUMMARY
Skeletal myopathy in systemic sclerosis (SSc) is associated with increased disability and mortality. There is no
consensus classification of SSc-associated myopathy that can be utilized to lay the groundwork for
understanding muscle disease in scleroderma. We know that there is pathological, serological, and outcome
heterogeneity that may be informative in defining distinct subsets of myopathy in SSc. Our preliminary data
demonstrate that (1) muscle histopathology is heterogeneous in SSc, (2) patients with a fibrosing myopathy
have poor outcomes, in particular cardiac death, and (3) there is intense signal uptake on advanced MRI
imaging such as diffusion weighted and tensor imaging and T2 mapping in SSc-associated myopathy which
may indicate early disease related changes when compared to conventional muscle MRI. This K23 proposal
will first establish a Myopathy cohort (Aim 1), devise a classification schema and test its utility in predicting long
term outcomes such as trajectory, cardiopulmonary disease, disability, mortality, and treatment
responsiveness(Aim 2), and detect and quantify early disease related muscle changes on advanced muscle
MRI (Aim 3). This application is for a K23 award for Julie Paik, MD, MHS, Assistant Professor of Medicine in
the Division of Rheumatology at the Johns Hopkins University. Her long term career goal is to become a
leading clinical investigator in scleroderma muscle disease in the context of observational cohort studies, state
of the art imaging biomarkers, and clinical trial methodology. Her short term goal of devising this classification
schema will provide a new gold standard for the validation of external myopathy cohorts in SSc and lay the
framework for future studies directed at understanding biological mechanism and developing a therapeutic trial
using measurable outcomes such as quantitative muscle MRI. This proposal takes advantage of the rich
resources and infrastructure at the Johns Hopkins Scleroderma Center, a recently designated Precision Center
of Excellence in 2018. Her mentoring team includes Dr. Laura Hummers and Dr. Fredrick Wigley, both
renowned experts in SSc and clinical epidemiology, Dr. Andrew Mammen is an internationally recognized
myositis expert, and Dr. Scott Zeger a leader in bio statistical and epidemiological research. Dr. Paik has
recruited vital members to her Advisory Committee, composed of mentors and collaborators who have specific
expertise relevant to the proposal and are fully supportive of Dr. Paik’s research and career goals. These
include Dr. Michael Jacobs (advanced radiological imaging), Dr. Laura Fayad (musculoskeletal radiology), Dr.
Andrea Corse (muscle histopathology), Dr. Tom Lloyd (classification schemas in inclusion body myositis), and
Dr. Ami Shah (scleroderma translational research). This K23 award will allow Dr. Paik to gain the skills needed
to analyze and develop a classification schema of skeletal myopathy in scleroderma, develop expertise in
advanced muscle MRI analysis, and build her clinical trial skill set to ultimately support a future R01 proposal.

Public health relevance
PROJECT NARRATIVE The proposed research will establish a comprehensive, prospective myopathy cohort in systemic sclerosis (SSc or scleroderma) to ultimately devise a novel classification schema for SSc-associated myopathy that is predictive of outcomes such as treatment response, disability, cardiopulmonary disease trajectory, and death. Advanced muscle MRI techniques include diffusion weighted imaging, diffusion tensor imaging, and T2 mapping will also be used to detect and quantify early muscle disease related changes in SSc associated myopathy. The knowledge gained from this study will lay the foundation for discovering predictive biomarkers of disease course and to allow future studies of the specific biological process involved in each phenotype.